Effect of nicotine on elements of attention in smokers and nonsmokers

Many cigarette smokers report that smoking helps them stay alert and improves their concentration. Early research tended to support the idea that smoking enhanced human performance; however, many of these studies only demonstrated that smoking reversed withdrawal-induced performance deficits in nicotine-dependent individuals. More recent research has indicated that smoking or nicotine can truly enhance certain aspects of attention and memory. We have recently completed the first of a planned series of studies investigating the effect of varying doses of intranasal nicotine on attention and cognition. This initial study was designed to determine whether we could achieve dose-related effects of nicotine (0, 1, 2, mg) in a single test session. Nicotine dose-dependently increased subjective ratings of alert, head rush, and stimulated, and decreased ratings of relaxed, urge to smoke, and drowsy. Nicotine also increased heart rate and blood pressure. Nicotine dose-dependently increased correct responses and decreased omission errors on a test of sustained attention. Accuracy on an arithmetic test was also enhanced by nicotine in a dose-related manner. In both tests, there was no difference between 12-hr tobacco-deprived and nondeprived conditions. In future studies, we will use this dosing paradigm to investigate the effect of nicotine in smokers and nonsmokers on the various elements of attention: encode, focus/execute, shift, sustain, and stabilize.